Validating novel DNA repair deficient cancer therapy targets and small molecule compounds

Abstract
Single-strand DNA repair (ssDR) is critical for preventing genomic catastrophe. AnaNeo Therapeutics was
founded by experts in DNA repair mechanisms. Extending our team’s previous fundamental ssDR studies we
analyzed >61,000 tumors for somatic mutations, generated isogenic mutant/wild-type cell line pairs, screened
two isogenic cell line pairs with small molecule libraries, performed computational and experimental synthetic
lethality (SL) screens and used state-of-the-art Schrodinger Maestro drug docking software to nominate small
molecule ssDR SL hits. Here in this Phase I STTR project we propose to validate candidate targets and small
molecule inhibitors. Overall, this study will nominate innovative ssDR SL precision therapy targets and small
molecule hits for lead optimization in future Phase II SBIR studies.

Public health relevance
Single-strand DNA repair is critical for preventing genomic catastrophe. We have screened drug and gene mutation libraries to identify novel cancer therapy compounds for tumors that carry DNA repair mutations. This study will validate innovative precision cancer therapy targets to help patients whose tumors carry DNA repair mutations.